Nebraska Center for the Prevention of Obesity Diseases through Dietary Molecules

SUMMARY – PARENT PROJECT
The Nebraska Center for the Prevention of Obesity Diseases through Dietary Molecules (NPOD) at the University
of Nebraska supports research on the identification of biological signals that prevent, treat, and cure obesity and
related diseases. The emphasis of NPOD is on food-borne signals. Led by the University of Nebraska-Lincoln
(UNL) in close collaboration with the University of Nebraska Medical Center, NPOD investigators have their
tenure homes in 16 units crossing basic and clinical sciences, including nutrition, chemical engineering,
biochemistry, gastroenterology, and public health, making NPOD a truly multidisciplinary endeavor. NPOD's
long-term goal is to enhance the biomedical research infrastructure in Nebraska while combating obesity, a major
health problem impacting U.S. citizens. NPOD's Centers of Biomedical Research Excellence (COBRE) Phase 1
successes include over $96M in external funding awards to support research and 375 scholarly publications on
the center's theme. Ten junior investigators have been mentored through two cohorts, with four of the five Cohort
1 project leaders graduating from NPOD support and establishing themselves as independent investigators
within the center. The fifth project leader departed for a position in Europe prior to graduation. Cohort 2's five
project leaders are in the middle of their mentoring period. The hire of four new faculty during Phase 1 enabled
the center to lay the groundwork necessary to establish a critical mass of researchers: NPOD's membership has
grown from 13 faculty at the center's inception to its current count of 51 investigators. During Phase 1, NPOD
renovated space on the UNL campus to create a research core and installed new equipment in the core worth
$738,500 to meet the evolving needs of center members. An Administrative Core provides oversight of program
activities to ensure the center functions effectively. NPOD's many successes in Phase 1 have positioned it to
leverage Phase 2 COBRE funding via strategic activities designed to maximize center success. Specifically,
NPOD will 1) increase its critical mass of researchers by hiring an additional five junior investigators at the
University of Nebraska, recruiting new junior and senior investigators to the center using pilot and seed grant
funding, and continuing to develop strategic alliances with complementary programs across the state of
Nebraska; 2) acquire additional equipment for the research core and formalize experimental design
services offered through the administrative core; 3) enhance the center's mentoring structure and
collaborative, multidisciplinary environment; and 4) implement hiring and recruitment approaches to expand
integration of fundamental nutrition and obesity research with clinical, translational, and community research. By
the completion of Phase 2, NPOD will be on-track for transitioning into COBRE Phase 3 and then pursuit of
NPOD's vision to become an NIH-designated Nutrition and Obesity Research Center.

Public health relevance
NARRATIVE – PARENT PROJECT More than 60 percent of Americans are obese or overweight and the medical care costs associated with their treatment are significant, totaling $147B to $210B per year. The Nebraska Center for the Prevention of Obesity Diseases through Dietary Molecules (NPOD) is playing a key role in helping to combat this epidemic by providing a multidisciplinary environment that enables researchers to identify the biological, and specifically food-borne signals necessary to prevent, treat, and cure obesity and related diseases. Within the framework of obesity- related diseases, non-alcoholic fatty liver disease (NAFLD), which impacts 20% of U.S. adults and has lifetime treatment costs up to $36,000 per individual, has emerged as a particular area of strength in NPOD.